Perfluoroalkyl substances and breast cancer tissue biomarkers

PROJECT SUMMARY
Per- and polyfluoroalkyl substances (PFAS) are possible carcinogens and have demonstrated detrimental
effects on the mammary gland in experimental studies. PFAS are widely used in non-stick, water-resistant, and
stain-resistant coatings for consumer products. Nearly all U.S. residents have detectable PFAS in their blood,
and their environmental persistence and potential for bioaccumulation raises significant concerns about their
long-term health effects. Epidemiologic studies offer preliminary evidence that exposure to certain PFAS may
be associated with a doubling of breast cancer risk, and laboratory studies also support breast carcinogenesis
following PFAS exposure. Exploring morphological features of human breast tissue can provide important
insight on breast carcinogenesis and the impacts of specific exposures. No prior studies have directly explored
how human breast tissue is affected by PFAS exposure. Terminal ductal lobular unit (TDLU) involution and
mammographic density (MD) are features of human breast tissue that are strongly and independently
associated with breast cancer risk and likely lie on the causal pathway. Our overall goal is to understand if
PFAS contribute to breast cancer development. Toward this goal, we propose a novel investigation to
understand if serum concentrations of common PFAS are associated with TDLU involution and MD. We will
leverage the unique resources of the Susan G. Komen for the Cure Tissue Bank (KTB) biorepository, which
includes ~9,000 samples of breast tissue donated by healthy volunteers along with relevant epidemiologic data
(e.g. medical history, reproductive history); a subset of volunteers also provided a blood sample and/or access
to mammograms. We will select the 286 postmenopausal KTB donors with available: a) stored serum sample,
b) prior TDLU measurements, and c) mammogram. We will measure a panel of common PFAS in serum
samples using a validated assay at a highly experienced and reputable laboratory. We will address the
following Specific Aims: to assess associations between serum PFAS concentrations and quantitative
measures of 1) TDLU involution and 2) MD. We have an excellent opportunity to capitalize on pre-existing data
and biospecimens from the KTB for an innovative exploration of PFAS and these breast tissue features, each
of which is independently predictive of breast cancer risk. The proposed work will provide insight on
physiologic mechanisms and generate critical preliminary data critical for future larger epidemiologic studies of
PFAS and breast cancer risk. As PFAS exposure is ubiquitous, even a small association with breast cancer
risk would substantially impact public health.

Public health relevance
PROJECT NARRATIVE Per- and polyfluoroalkyl substances (PFAS) are possible carcinogens with demonstrated detrimental effects on mammary gland development and function in experimental studies. We have an excellent opportunity to capitalize on pre-existing data and biospecimens from the Susan G. Komen for the Cure Tissue Bank for an innovative exploration of PFAS and two morphological breast tissue features that are predictive of breast cancer risk: terminal ductal lobular unit involution and mammographic density. The proposed work will provide insight on physiologic mechanisms and generate critical preliminary data supporting future larger epidemiologic studies of PFAS and breast cancer risk.